Applying a Behavioral Economic Approach on PrEP Options

Modified Project Summary/Abstract Section

Daily and intermittent/2-1-1 pre-exposure prophylaxis (PrEP) options are promising to end the HIV epidemic among participants in the Philippines where the HIV case infections recently doubled (1560 cases in 2022 vs. 714 in 2019) within a short timeline in this population. Understanding end-user input and preferences of PrEP via behavioral economic approaches like conjoint study designs are vital to maximizing its effectiveness such as feasibility, acceptability, and sustainability across its care continuum. However, to our team's knowledge, no conjoint design studies have been applied to examine participants' end-user preferences for PrEP, including the co-use of hormone therapy. Moreover, the socio-ecological facilitators and challenges pertinent to influencing PrEP uptake across the personal, social, economic, and structural levels are underexamined among this population. As such, along with this study's Stakeholder and Scientist Advisory Board, this proposal aims to inform and test a future behavioral economic-based intervention to support PrEP engagement among participants in the Philippines, with the following aims: (1) To qualitatively explore and identify all preferred and accepted attributes and features of PrEP needed to inform a full-profile PrEP program choice-based conjoint survey study via in-depth interviews with 30 participants and 15 key informants (i.e., HIV specialists, primary care providers, PrEP programmers/policymakers), and (2) To quantitatively test and determine optimal combinations of attributes predictive of participants' acceptability and preferences about PrEP modalities via full-profile choice-based conjoint study design with 300 participants in the Philippines to enhance implementation outcomes (e.g., acceptability, feasibility) of future intervention, and examine socio-ecological factors that may influence the chosen optimized PrEP program preferences. Findings will provide pilot data insights to test the identified optimized PrEP program profile(s) via a future larger scale (R01) behavioral economic-structural strengthening intervention for participants in the Philippines to increase PrEP uptake and reduce HIV incidence in the Philippines.

Public health relevance
Modified Public Health Relevance Section This study proposes to examine and test, via behavioral economic choice-based conjoint study design, optimal combinations of product attributes and features predictive of participants' acceptability and preferences for pre-exposure prophylaxis (PrEP) in the Philippines, including preferences for co-use of hormone therapy options. The results provide foundational data insights to address and improve engagement across PrEP options and co-use of hormone therapy, and test via a future larger scale (R01) behavioral economic-structural strengthening intervention, the identified optimized PrEP program profile(s), for participants in the Philippines.